Improving the diagnosis and treatment of medication adherence problems in HIV

DESCRIPTION (provided by applicant): This proposed renewal of Dr. Wilson's K24 builds on the strong record of success achieved during the first 6 years of this award. Since the start of his K24 in 2003 he has mentored 52 individuals, including 19 whom he is currently mentoring. During this time his mentees have produced 26 first author published manuscripts and 19 first author abstracts. Eight mentees have gone on to be awarded K23's, and 3 to receive R-series awards. The research environment at Tufts Medical Center and Tufts University is highly conducive Dr. Wilson's patient-oriented research and provides several different sources for mentees, and as of 2008 includes a Clinical Translational Science Award (CTSA). Dr. Wilson is Co-PI of the Tufts CTSA and a Director of the Tufts Clinical and Translational Research Portal, which means that the scope of his mentoring is now University wide. The patient oriented research of Dr. Wilson and his mentees focuses on problems with medication adherence in persons with HIV. Despite the availability of one pill once daily treatment for HIV, poor adherence with HIV antiretroviral therapy (ART) clearly continues to be a problem for HIV care providers worldwide. It is also clear that non-infectious comorbidity such as diabetes and cardiovascular disease is increasingly common in persons with HIV, and that medications required for these other conditions further complicate patients' adherence efforts. Progress on this important global problem requires that we be able to quickly and inexpensively identify patients with adherence problems, and that we have interventions to implement in response that target patients' individual needs. That is, we need to both better diagnosis and better treatment. The long term goal of this research is to link the accurate and timely diagnosis of medication adherence problems with customized treatments that are patient and medication specific. The overall research objective of this K24 is to complete a series of 5 significant and novel Aims, all of which focus on improving the quality of diagnosis and treatment of medication adherence problems in persons with HIV. The overall mentoring objective of this K24 is to develop researchers who not only have the skills to develop, implement, and publish hypothesis driven, patient-oriented research, but who understand the importance of bringing a multi-method, multi-disciplinary approach to clinical and translational research problems. In his mentoring Dr. Wilson emphasizes the importance of tailoring research methods to the nature of the problem of interest, even if that means learning new methods or developing collaborations with others from other disciplines familiar with those methods. The proposed research is relevant to the NIH's mission because it attempts to improve the quality of care for patients with a prevalent and serious, but highly treatable, chronic condition, and because the lessons learned from this HIV-related work are directly applicable to the care patients with other chronic conditions.

Public health relevance
Improving the health outcomes of persons with chronic conditions generally requires lifelong adherence with effective medications, which most patients find difficult. The patient-oriented research proposed in this K24 focuses broadly on improving both the diagnosis and treatment of medication adherence problems in persons with HIV. In addition, the mentoring plan that Dr. Wilson will implement will contribute to the training of the next generation of researchers to continue this important multidisciplinary work. While this K24 focuses on HIV, the lessons learned from this work are directly applicable to the care patients with other chronic conditions.